Valency and distance co-optimized peptide bound PEG-b-PPS Filomicelles hydrogel depot for anti-integrin therapeutics

1 Project Summary: Anti-integrins are considered as promising alternative for angiogenesis related disease
2 conditions including cancer, Crohn’s, and retinal diseases. However, an optimal nanomaterial design by
3 considering the application and target cell receptor expression is extremely vital for the success of the
4 formulation. Although polymeric nanocarriers have demonstrated considerable potential associated with anti-
5 integrin peptide delivery, the peptide valency and surface distance are rarely co-optimized to enhance
6 therapeutic ligand clustering. Hence, the primary goal of this proposal is to develop and validate a novel
7 bioresponsive hydrogel depot for the sustained delivery of micelles carrying therapeutic peptides at an optimal
8 valency for therapeutic efficacy. A key innovation of this proposal is that we will use self-assembled poly(ethylene
9 glycol)-b-poly(propylene sulfide) (PEG-b-PPS) filomicelles (FM) that use cylinder-to-sphere thermodynamic
10 transitions for sustained in situ generation and delivery of peptide-loaded micelles (MC). In this proposed work,
11 the peptide’s valency and distance from the MC surface will be co-optimized for an efficient therapeutic effect.
12 As proof of concept, the current proposal will use an anti-integrin heptapeptide that showed therapeutic efficiency
13 in vitro using HUVEC cells. With the strong initial results, the objective of the current proposal is to study the
14 mechanistic investigation of the FM-hydrogel depot through in vitro, ex vivo and in vivo investigations and
15 generate preliminary data for future translational grant mechanisms involving appropriate animal disease
16 models. Ex vivo model in this proposal will assist in selecting the optimum formulation and reduce the use of
17 animals and align with the current grant mechanism. The following specific aims will be achieved:
18 AIM 1: Synthesize, optimization and In vitro characterization of FM-depots for the sustained release of MCs
19 displaying a co-optimized surface display of anti-integrin peptide (aANG-P). Aim 1a will address the development
20 of FM-depots with aANG-P constructs, verify control over the MC release rate and confirm that peptide valency
21 and bioactivity remain unchanged following the FM-to-MC transition. Aim 1b will study the inflammatory response
22 induced by FM depot using primary macrophages and confirm of therapeutic activity of the released MC using
23 HUVECs and macrophage cells.
24 AIM 2: Ex vivo and in vivo tissue distribution and bioactivity of aANGP-MC released from aANG-P FM-depots.
25 Aim 2a will study the micellar release kinetics, and tissue distribution from aANGP-FM injected suprachoroidal
26 space of excised rabbit whole eye and study the bioactivity using choroid sprouting assay and CAM assay. Aim
27 2b will confirm the tissue distribution of the aANGP-FM depot using Sprague Dawley rat model and study the
28 inflammatory response after injecting at suprachoroidal space.
29 The overall outcomes of the proposed project will be a nanomaterial-based translational approach that will
30 provide a novel sustained and prolonged release technology for ligand targeted retinal drug delivery which can
31 counter the complication of current technologies, which is a key focus of the NIH/NIBIB mission.

Public health relevance
Project narrative: The proposal is to develop a hydrogel depot for the delivery of micelles that display an anti- integrin peptide with optimum valency (density on micelles) and distance from the nanocarrier to overcome the limitations of ligand targeted therapy. The proposed project is relevant to public health will provide a novel sustained and prolonged release technology for ligand targeted drug delivery which can be applicable to various disease conditions, which is a key focus of the NIH/NIBIB mission.